Antibody responses to viruses

This research was primarily carried out by a cooperating laboratory. Through the use of single-cell BCR cloning and other techniques, antibody responses were characterized in a patient with a history of SARS-CoV2 infection and elite serum neutralization activity. One study identified broadly neutralizing antibodies that can neutralize all SARS-CoV2 variants and dissected the importance of somatic mutations for neutralization breadth and potency. Another study focused on those antibodies that are cross-reactive to SARS-CoV1 and to SARS-CoV2 variants. One key finding was that SARS-CoV1 cross-reactive antibodies evaded the SARS-CoV2 Omicron lineage and the escape mechanism was documented through structural analyses. Collectively, these studies improve our understanding of human antibody responses to sarbecoviruses.